Assessment of Survivor and Provider Perception of Trauma and Violence Informed Care Among Black Women (ASAP-TVIC in Black Women)

Rates of intimate partner violence (IPV) homicides are three-fold higher among Black women and IPV-related
deaths rob Black women of at least a decade of life relative to White women. Lifetime IPV prevalence is also
higher among Black (50%) than White (35%) women. This persistent and disproportionate impact of IPV for
Black women strongly suggests the need for an intersectionality framework to inform IPV intervention and
prevention services for Black women delivered by health care providers. The American College of Obstetrics &
Gynecology (ACOG) recommends routine IPV screening and supports implementation of `trauma-informed
care with close attention to avoiding stigmatization and prioritizing resilience'. As a Tennessee-based HBCU,
Meharry Medical College is ideally positioned to heed ACOG's call to action. We propose the use of an
intersectionality framework to inform the adaptation, implementation and evaluation of clinic-based trauma and
violence informed care (TVIC) intervention. Meharry is home to an evidence-based trauma-informed care
intervention for HIV care; this intervention will inform our IPV focused intervention's development. To support
women's health equity and actualize ACOG recommendations, we propose the adaptation, implementation,
and rigorous evaluation of an innovative TVIC intervention. By using an intersectionality framework in the
adaptation of our TVIC intervention, we seek to ensure its relevance for Black women. Our primary goal is
the adaptation, implementation and evaluation of a TVIC intervention designed for Black women in
Central Tennessee. In this 5-year RCMI project, we propose 3 aims. Aim 1) Engage a stakeholder committee
of patients, providers, and experts (COPE) to adapt a trauma & violence informed care (TVIC) intervention for
Black women and their healthcare providers at Meharry. [Years 1-2]. Aim 2) Implement and prospectively
evaluate the adapted TVIC intervention at the healthcare provider-level, measuring changes in Meharry
healthcare provider's self-efficacy for TVIC implementation and alignment with TIC knowledge, attitudes, and
practices. [Years 2-3] Aim 3) Implement the adapted TVIC intervention at the patient-level to provide trauma-
informed IPV screening, brief interventions, and referrals to treatment (SBIRT), and rigorously evaluate this
TVIC intervention's impact on the primary outcome of patient-perceived usefulness of intervention and reported
linkage to IPV services, and the secondary outcome of changes at the clinic-level relative to climate and
culture, through a non-randomized pragmatic trial design. [Year 4-5]. Meharry's mission of `advancing health
equity through innovative research' and `compassionate health services' make this HBCU an ideal setting for
this innovative and impactful research. This research has the potential to transform the care Black women who
experience IPV receive with the goal of addressing the disproportionate impact IPV has for Black women. Early
detection of IPV via universal screening coupled with IPV-related trauma-informed care can reduce the range
of IPV-associated mental and physical health consequences and medical costs, estimated at $2.1 trillion USD.

Public health relevance
One in four women experience sexual, physical violence and/or stalking by an intimate partner. Black women are disproportionately affected by intimate partner violence (IPV) and the debilitating symptoms of trauma associated with IPV. In this IPV-focused proposal we seek to adapt, implement, and test an IPV intervention using trauma-informed care practices for Black women in central Tennessee.